Role of Selective Autophagy in Organismal Health

PROJECT SUMMARY
Autophagy is a cellular, homeostatic process with important roles in aging and age-related diseases. During
autophagy, cytosolic material or cargo is sequestered into autophagic vesicles called autophagosomes for
subsequent lysosomal degradation; however, the underlying mechanisms for how the turover of specific types
of cargo, e.g., protein aggregates or mitochondria, collectively referred to as selective autophagy, contributes
to cellular proteostasis and organismal health remain elusive.
We and others recently showed a conserved role for the first identified autophagy cargo receptor in
metazoans, p62/SQSTM1 in mediating proteostasis and organismal benefits in an autophagy-dependent
manner. In particular, we showed that p62 overexpression in the short-lived nematode C. elegans is sufficient
to induce autophagy and extend life- and healthspan, and protect against protein aggregation predominantly in
neurons. Moreover, p62 is selectively required for the beneficial effects of a hormetic heat shock, a conserved
longevity regimen that we previously showed to induce autophagy. Collectively, these studies suggest the
hypothesis that p62 plays an instructive role in inducing tissue-specific, selective autophagy to facilitate
organismal benefits. This is a novel concept because autophagy receptors are traditionally viewed as factors
facilitating cargo sequestration, rather than being active inducers of this complex, multi-step turnover process.
We propose to address this hypothesis by using C. elegans to investigate the molecular mechanisms by
which a hormetic heat shock via p62 or direct p62 overexpression regulate autophagy cell autonomously and
improve organismal health via cell non-autonomous effects. Specifically, in Aim 1, we will use genetic
approaches to test how a hormetic heat shock engages p62 to regulate autophagy especially in neurons. In
Aim 2, we will investigate the cell-autonomous and cell non-autonomous mechanisms by which p62 induce
autophagy and improve fitness. Finally, in Aim 3, we will use genetic and biochemical approaches to identify
new p62-relevant cargo and p62-like receptors engaged by hormetic heat shock. These studies are significant
because they will advance our knowledge of how selective autophagy contributes to organismal healthspan.
These studies are innovative because they use a powerful combination of techniques and models to
investigate the novel regulatory concept in the autophagy field that an autophagy receptor is sufficient to
induce beneficial autophagy, potentially via cell non-autonomous mechanisms. Since autophagy plays critical
roles in many human age-related disorders, understanding the regulation of autophagy and the conserved
mechanisms by which autophagy affect aging in multicellular organisms like C. elegans are likely to provide
new important insights relevant to aging, which also may help develop treatments for age-related diseases.

Public health relevance
PROJECT NARRATIVE The US population of elderly people is rapidly growing and age-related diseases constitute a major health issue in our society; however, the cellular and molecular basis of aging and age-related disorders is poorly understood. This proposal aims to determine how autophagy – a cellular process of cytoplasmic degradation with major biological functions – modulates organismal aging. The proposed research has relevance to public health, because the mechanisms to be investigated are evolutionary conserved and the findings might ultimately provide therapies to treat aging-related diseases.